High-content microscopy platform for multiplex perturbation/multiplex readout studies

NOT-GM-24-021 – ABSTRACT – HART
Highly multiplexed genetic perturbations offer huge potential beyond fitness screens. High throughput
microscopy offers a tractable method for combining complex genetic perturbation with multiparameter functional
assays. Here we propose the purchase of a Nikon Eclipse Ji microscopy system to facilitate complex data
collection to decipher the complexity and redundancy of mammalian signaling pathways. Using our next-
generation CRISPR/Cas12a polygenic knockout system, we combine custom CRISPR arrays targeting signaling
effectors and cell surface “barcodes”, then use immunofluorescence readouts of cell state across dozens of
targets – two to four per well in a 96 well plate -- to understand the dynamics of cell signaling.

Public health relevance
NOT-GM-24-021 – NARRATIVE – HART Highly multiplexed genetic perturbations offer huge potential beyond fitness screens. High throughput microscopy offers a tractable method for combining complex genetic perturbation with multiparameter functional assays. Here we propose the purchase of a Nikon Eclipse Ji microscopy system to facilitate complex data collection to decipher the complexity and redundancy of mammalian signaling pathways. Using our next- generation CRISPR/Cas12a polygenic knockout system, we combine custom CRISPR arrays targeting signaling effectors and cell surface “barcodes”, then use immunofluorescence readouts of cell state across dozens of targets – two to four per well in a 96 well plate -- to understand the dynamics of cell signaling.